Noninvasive Phenotyping of Respiratory Function in People with Muscular Dystrophies Using Electrical Impedance Tomography

PROJECT SUMMARY
The muscular dystrophies (MDs) are rare disorders that consist of over 30 genetic diseases that
cause progressive muscle weakening and deterioration with Duchenne muscular dystrophy as the
most common and most debilitating form, affecting about 1 on 3,500 live male births per year.
Respiratory problems are a common symptom in persons with MDs due to weakness of
inspiratory and expiratory muscles. However, the onset and pattern of respiratory symptoms
varies according to the specific muscular dystrophy and stage of progression. Across all of the
dystrophies, the most common cause of death is respiratory failure. To support respiration as the
disease progresses, patients eventually receive non-invasive ventilatory support (NIV). However,
the decision as to when NIV should start is subjective and is informed by pulmonary function tests
(PFTs) and sleep studies. Unfortunately, pulmonary function tests cannot always be performed
due to cognitive or physical disability or age. Sleep studies have the disadvantages that they are
obtained in artificial environments, patients may not tolerate the measuring equipment, and
patients may not sleep. Thus, there is a need for an objective surrogate for sleep studies to inform
the decision as to when NIV is recommended.
Electrical impedance tomography (EIT) is a noninvasive, non-ionizing real-time functional
imaging technique with no harmful side effects, suitable for patients of any age. We will study the
effectiveness of EIT as a measure of lung function longitudinally and as a surrogate for metrics of
ventilation obtained during sleep lab studies in patients with muscular dystrophy. We will
compare the EIT measures between dystrophies to determine whether their outcomes have the
same meaning across the dystrophies. To accomplish this, we will carry out the following specific
aims: (1) Develop a 3-D algorithm and a new method of segmentation to improve accuracy of EIT
images and derived measures of ventilatory heterogeneity. (2) Assess lung function and
heterogeneity longitudinally in patients with MD using EIT. (3) Determine the correlation of EIT
measures with ventilation metrics obtained during a sleep study in patients with muscular
dystrophy.

Public health relevance
Public Health Relevance Statement The muscular dystrophies affect approximately 250,000 people in the United States, and the most common cause of death is respiratory failure. Disease progression and treatment strategies are informed by pulmonary function tests and sleep lab studies, but each of these has serious shortcomings for persons with muscular dystrophy. This work will investigate the effectiveness of a noninvasive and non-radiating imaging tool known as electrical impedance tomography (EIT) as a measure of lung function longitudinally and as a surrogate for metrics of ventilation obtained during sleep lab studies in patients with muscular dystrophy.